Pro-youthful role of Gpld1 on regenerative and cognitive function in the aged brain

PROJECT SUMMARY/ABSTRACT
Identifying novel therapeutics to delay, and potentially reverse, age-related cognitive decline is critical in light of
the increased incidence of dementia-related disorders forecasted in the growing elderly population. Exercise has
been shown to rejuvenate regenerative capacity and cognition in the aged brain in animal models. Moreover,
exercise has been shown to improve learning and memory in Alzheimer’s disease patients. Excitingly, our lab
recently demonstrated that systemic administration of blood plasma derived from exercised mice reverses age-
related impairments in adult neurogenesis and cognition in aged mice. We identify glycosylphosphatidylinositol
specific phospholipase D1 (Gpld1) as a liver-derived exercise blood factor – the plasma levels of which correlate
with improved cognitive function in aged mice, and the levels of which are increased in active healthy elderly
humans. Functionally, we show that increasing liver-derived systemic Gpld1 in aged mice ameliorates age-
related regenerative and cognitive impairments. These data raise fundamental questions as to the function of
liver-derived systemic Gpld1: How long lasting are the rejuvenating effects of systemic Gpld1 on the aged brain?
What is the role of systemic Gpld1 in mediating the rejuvenating effects of exercise on the aged brain? 3. What
molecular mechanisms underly the rejuvenating effects of systemic Gpld1 in the aged brain? The purpose of the
proposed study is to investigate the rejuvenating effects of systemic Gpld1 on the aged brain. Specifically, our
hypothesis is that exercise-induced liver-derived systemic Gpld1 elicits long lasting rejuvenation of regenerative
and cognitive functions in the aged hippocampus. We will test this theory with Three Specific Aims: 1:
Characterize the kinetics of brain rejuvenation following increased liver-derived systemic Gpld1. 2: Investigate
the necessity of exercise-induced systemic Gpld1 in mediating the rejuvenating effects of exercise on the aged
brain. 3: Determine molecular mechanisms underlying the rejuvenating effects of liver-derived systemic Gpld1 in
the aged brain. Successful completion of these studies will have significant translational potential, revealing
pathways that could be targeted for novel therapies to ameliorate age-related neurodegenerative diseases such
as Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE The research described in this proposal challenges longstanding views that the aged brain is unable to combat the effects of aging due to a lack of inherent plasticity, which facilitates permanent age-related regenerative and cognitive impairments. By exploring how regenerative and cognitive functions can be enhanced through increased systemic Gpld1 we aim to move closer towards realizing the possibility of reversing age-related cognitive impairments in the elderly. Moreover, this study will have significant translational potential, revealing pathways that could be targeted for novel therapies to ameliorate age-related neurodegenerative diseases such as Alzheimer’s disease.